Dissecting neomorphic functions mediated by mutant-specific structures of SPOP

Summary
Mutations in the ubiquitin-proteasome system (UPS), including in ubiquitin-ligase components such as VHL,
BRCA1, FBW7, APC and SPOP, lead to deregulation of protein levels and can drive tumorigenesis. Therapeutics
against such UPS components are therefore promising, but toxic on-target effects on the wild-type protein in
normal cells can severely limit tolerated doses and the therapeutic window. Mutant-specific therapeutics could
overcome these limitations. Hence, the characterization of cancer mutants that adopt different structures than
WT proteins is of importance for making progress in the direction of mutant-specific therapies. Here we propose
to capitalize on recent breakthroughs from my laboratory, in which we solved the first structure of full-length
SPOP (the Speckle-type POZ protein), which is a substrate receptor of the Cullin3-RING ubiquitin ligase (CRL3)
and recruits substrates to the ligase for their ubiquitination and subsequent degradation. SPOP is frequently
mutated in prostate, endometrial, and other solid tumors. Our structure of SPOP reports new protein-protein
interfaces that have not been observed in previous structures of partial SPOP constructs. These interfaces are
lined with mutations whose underlying molecular mechanism was so far not understood because the mutated
residues seemed to be solvent exposed. Furthermore, the structures of two SPOP endometrial cancer mutants
and other preliminary data show that these activating cancer mutations have effects on the higher-order structure
of SPOP that differentiate them decisively from the WT structure: (i) They shift the equilibrium between a linear
filament and a circular donut state, the latter of which is likely inactive based on several lines of preliminary data.
Or (ii) they radically alter the higher-order assembly structures. We will capitalize on our recent progress and
integrate structural characterization with our previously developed biophysical, biochemical and cell biological
tools and reagents to answer the following questions: (1) How does self-association into different states,
including linear and circular oligomers, regulate SPOP function? (2) Do the structure-altered SPOP mutants
function through their altered structural states? (3) And what is the potential of SPOP mutants to form altered
quaternary assemblies? The expected structures of donut states and active complexes will be interrogated by
mutagenesis and supplemented with functional assays in vitro and in cells to dissect the molecular mechanisms
underlying their super-physiological function. We expect to gain decisive insight into the question whether the
structurally altered forms are functionally important, with implications for targeting specifically the mutant forms.
We will also gain understanding of how higher-order assemblies can drive hyper-morphic or neo-morphic disease
phenotypes. Using machine learning models, we will make our results transferable to other cancer-associated
proteins whose function is intrinsic to their ability to form higher-order oligomers.

Public health relevance
Narrative If cancer therapies could be targeted specifically against disease mutants instead of the normal protein, adverse effects would be reduced, higher doses could be used, and cancer cells could be killed more effectively. Such mutant-specific therapies may be developed for proteins for which disease mutations change the overall structure. The studies proposed here will lead to structural and functional characterization of a protein that is frequently mutated in cancers and that forms altered assemblies when mutated, to make progress in determining the feasibility of this future therapeutic strategy.